Laser Treatment Modality for Strengthening Osteoarthritic Cartilage

Project Summary
Osteoarthritis (OA) is a debilitating degenerative disease that afflicts an estimated 27 million Americans age 25
and older. This disease leads to the progressive degradation of the articular layers of diarthrodial joints,
significantly compromising the main function of cartilage as a load bearing material, leading to pain and limiting
activities of daily living. To this day, there are very limited treatment options for slowing down the progression
of OA in its early stages. Most therapies, such as highly invasive partial and total joint replacement surgeries
are performed at the late stage of the disease. Introducing treatment options to earlier stages of OA presents
the potential to retard or slow down disease progression and thus significantly improve patient outcomes. The
primary function of articular cartilage is to transmit loads across the joint surfaces while simultaneously
minimizing friction and wear. This application describes the development of an ultrafast laser-based treatment
tool which has the ability to induce crosslinks into the cartilage collagen network without the addition of a
chemical agent, while simultaneously avoiding damaging effects of optical breakdown and ablation. Preliminary
data show that laser-induced crosslinks increase compressive stiffness and wear resistance, without
compromising cell viability, which may be expected to slow down progression of OA. The overall aim of this
application is to develop a range of effective and safe laser operating parameters that enhance cartilage
mechanical properties and wear resistance, enabling us to produce a clinically relevant protocol. We also aim
to assess the influence of laser-induced short-lived bursts of reactive oxygen species onto the long-term
response of cartilage during in vitro and in vivo culture. To translate this technology to future animal and
human studies, we will develop and test a laser-based clinical tool for arthroscopic treatment of cartilage in
situ. In specific aim 1, we will optimize a framework for structural, morphological and functional modification of
the cartilage extracellular matrix subject to femtosecond laser irradiation, using devitalized bovine and human
OA cartilage explants. In specific aim 2, we will narrow this range of operating parameters by testing short-term
and long-term viability of laser-treated live bovine and human OA (male & female) cartilage explants against
untreated controls, using in vitro culture up to 4 weeks. In specific aim 3, we will verify that laser-treated live
human OA cartilage explants exhibit comparable viability and health as untreated controls when implanted for
up to 8 weeks in the back of nude mice. We will also fabricate a fiber optic-based laser system and validate its
effectiveness in simulated in situ arthroscopic applications in OA knee joints. Upon completion of these
studies, we will have established effective and safe operating parameters for this novel laser treatment
modality, and created a practical tool to test this methodology in situ, first in large animals, then in humans.

Public health relevance
Project Narrative Early osteoarthritis (OA) of the knee and hip is most often associated with fibrillation and damage of articular cartilage, which eventually progresses to full-thickness defects and exposure of subchondral bone. To this day, there are very limited treatment options for slowing down the progression of OA in its early stages. The novel laser treatment technology proposed in this application, which can strengthen diseased cartilage by crosslinking its extracellular matrix without thermal damage, presents the potential to retard or slow down disease progression, thus significantly improving patient outcomes.